Path To Better Sleep + Virtual Coaching: The Effectiveness and Implementation of Internet-Based Self-Management Program for Insomnia in a Regional Healthcare System

Background: As many as 1.8 million individuals using VA services meet criteria for insomnia disorder, a
condition associated with suicide, poor functioning, and medical and mental health disorders. Cognitive
Behavioral Therapy for insomnia (CBTi) is the gold-standard treatment. However, only a small fraction of
Veterans receive CBTi due to a host of barriers. A digital intervention delivering CBTi, Path to Better Sleep
(PTBS), has been developed by VA specifically for Veterans. PTBS, enhanced by personal coaching, may
mitigate barriers to CBTi by enabling self-management beyond clinic walls.
Significance: Current PTBS dissemination practices consist of inadequate messaging, poor integration into
clinical workflow, and no personal support. Preliminary data indicate that while PTBS has increased access to
CBTi, only an estimated 0.8% of Veterans with insomnia disorder have visited the PTBS site. To address these
gaps, (1) coaching must be integrated with PTBS (Coached PTBS) to increase engagement/adherence and (2)
Coached PTBS must be embedded in current VA care practices using a scalable implementation strategy. The
prevalence of insomnia far outweighs VA’s capacity to deliver gold-standard treatment through any single
modality. An array of treatment options is needed. Moreover, PTBS coaching delivered through a hub-and-
spoke model is a scalable approach to MISSION Act directives mandating evidence-based care in rural areas.
Innovation and Impact: PTBS is the first digital CBTi designed for Veterans. PTBS is open access and meets
stringent VA information security requirements. Coaching integrated into PTBS will increase engagement and
adherence. A hub-and-spoke model of coaching limits reliance on local facility resources. A scalable
implementation strategy for digital interventions, optimized in prior research, will be used. The VISN 1 clinical
trials network allows access to a rural Veteran population and provides research coordination resources.
Specific Aims:
1. [Establish effectiveness of Coached PTBS when implemented in rural-facing VISN 1 facilities]
H1: Veterans randomized to Coached PTBS will report greater improvement in insomnia severity (primary)
and sleep parameters (secondary) compared to [PTBS + Contact (enhanced treatment as usual control)]
2. Evaluate the quantitative outcomes of REP-DI, the strategy used to embed Coached PTBS in VA care.
H2: REP-DI will result in adequate Reach among Veterans, Adoption among providers, and Maintenance.
3. Conduct a 3-part formative evaluation of implementation. Interviews with Veterans, providers, and staff will
be informed by constructs from the Consolidated Framework for Implementation Research (CFIR). Data
will optimize implementation in real time by tailoring implementation strategy elements to specific contexts.
Methodology: A pragmatic hybrid type-2 effectiveness/implementation mixed-methods trial will be used.
Outpatients with insomnia disorder will be referred by providers and randomized to Coached PTBS or PTBS +
Contact. The implementation strategy will be REP-DI, a scalable and resource efficient strategy for
implementing digital interventions. REP-DI will include provider training and augmentation of site referral
processes to support PTBS implementation. Outcomes will be evaluated according to the RE-AIM framework.
Outcomes include insomnia severity (primary), sleep parameters, fatigue, mood, sedative-hypnotic use, and
other measures collected at baseline, 8 weeks, and 6 months. REP-DI quantitative implementation outcomes
include Reach, Adoption, and Maintenance evaluated at patient and provider/staff levels. A 3-part formative
evaluation employing qualitative methods will identify patient and provider/staff determinants.
Next Steps/Implementation:
Coached PTBS can be implemented across VA using REP-DI by the National Center for Health Promotion and
Disease Prevention and secondary VA partners such as the Offices of Rural Health and Connected Care.

Public health relevance
PROJECT NARRATIVE Insomnia is a common and serious health condition associated with suicide and poor quality of life. Although cognitive behavioral therapy for insomnia (CBTi) is the gold-standard for care, few Veterans receive this treatment due to a host of barriers. The VA has developed a Veteran-oriented online version of CBTi called Path to Better Sleep (PTBS), which is free and available to all Veterans. PTBS has been widely advertised throughout the VA and Veteran service organizations. However, use of PTBS has been only modest. Prior research has shown that patients are more likely to participate in online treatments when supported by coaches. In addition, PTBS must be integrated into VA clinical workflow. The objective of this research is to evaluate the effectiveness of a coached version of PTBS and a scalable strategy for implementing Coached PTBS in VA care called Replicating Effective Programs for Digital Interventions (REP-DI). If effective, Coached PTBS implemented with REP-DI could expand Veteran access to insomnia treatment.